Regulation of T cell immunity to viral infection

SUMMARY:
Naive T cells have the potential to differentiate into effector cells with a range of functions that aid in clearing
pathogens as well as long-lived memory cells that provide protection from reinfection. CD4+ effector or T helper
cells are defined by the cytokines they produce, which mediate the activity of innate, B cell, and CD8+ T cell
immunity. The presence of numerous CD4+ T helper subsets has complicated the ability to define the
relationship between effector and memory-precursor populations and identify the molecular mediators required
to support the formation of CD4+ protective immunity. As CD4+ T cell help is required to sustain CD8+ T cell
memory in many contexts, to support high-affinity memory B cell responses, and to direct activity of innate
cells, we will seek to define the CD4+ memory T cell population(s) and their precursor(s) as well as the
transcriptional networks driving differentiation and homeostasis of this vital component of immune memory.
Further, our studies will explore the distinct differentiation requirements for CD4+ memory T cell populations
that reside in non-lymphoid tissues and circulating memory populations. Tissue-resident memory cells are of
particular interest in the context of vaccination as they provide essential sentinel protection at barrier surfaces,
and, are now clearly understood to be among the `first responders' in many infection settings. Using single-cell
analyses of protein and gene expression, genomic and computational approaches, and in vivo functional
screens as well as traditional adoptive transfers of cells that can report expression of or are mutant for
candidate regulators, we will comprehensively study CD4+ memory T cell formation in response to viral
infection. These studies will provide the basis to exploit the protective capacity of this vital memory T cell
population and modulate activity in the context of immunopathology. Direct targeting of specific transcriptional
regulators during vaccination holds promise as a novel strategy in the control of induced immunity.
!

Public health relevance
NARRATIVE: T cells responding to infection proliferate and acquire effector functions that directly mediate pathogen clearance and also modulate the activity of other immune cells. Following the resolution of infection, many of the T cells die, restoring homeostasis; however, a small number of pathogen-specific T cells survive providing long-lasting protection from reinfection or `memory'. Memory T cells can serve as sentinels, recirculating between blood, tissues, and secondary lymphoid organs, or take up permanent residence in barrier tissues providing a `front line' of defense—It is our goal to define these memory subsets and understand the signals and molecular pathways that promote the establishment and homeostasis of memory T cell populations. !